CORIELL - NINDS HUMAN GENETICS RESOURCE CENTER

NINDS is committed to providing well characterized cell sources to both academic and industry investigators to advance the study of neurological disorders. The specific objective of this contract is to receive, process, store, and distribute biological samples and associated phenotypic and genotypic data and manage and track all associated data and human subjects materials for National Institute of Neurological Disorders and Stroke (NINDS) to help facilitate or further develop treatments for neurological disorders.